Understanding the role of adiposity and adipokine-related RNA expression in the tumor microenvironment on breast cancer outcomes in a racially and ethnically diverse sample

ABSTRACT
The mechanisms linking adiposity with breast cancer and how variation in adipose tissue distribution contribute
to inequities in breast cancer recurrence and mortality remain to be determined. Untangling the complex
interactions among adiposity, race and ethnicity, and breast tumor phenotype is a first step, which requires
precise adiposity measures and identification and refinement of adiposity-associated biomarkers within breast
tumor tissues that can predict breast cancer outcomes. Our preliminary research has shown that the distribution
of visceral adipose tissue and subcutaneous adipose tissue – assessed by computed tomography (CT) – scans
differ by race and ethnicity and outperforms body mass index (BMI) in predicting cancer outcomes. Our prior
research also showed that gene and protein expression of the adipokines, leptin and adiponectin, and their
receptors vary in breast tumor tissues and generally, lower expression is associated with more aggressive tumor
features (e.g., higher grade, larger size, hormone receptor negative status, and triple-negative subtype). Further,
we found that increased body fatness measures – general obesity (BMI), body fat distribution (waist
circumference, hip circumference, WHR), and body composition (fat mass index, percent body fat) – are
associated with higher leptin receptor protein expression in breast tumor tissues, with evidence of effect
modification by race. Building on these preliminary studies, we hypothesize that adipose tissue depots (visceral
vs. subcutaneous) have differing associations with adipokine and adipokine receptor expression profiles and
related gene signatures in the breast tumor microenvironment (TME). Using multiplex RNA in situ hybridization
to characterize the abundance of adipokine and adipokine receptor expression in the breast TME, CT scans to
assess adipose tissue distribution, and RNA-seq for transcriptomic analysis in a large, diverse cohort of 1600
women with breast cancer, we will: (1) Test whether adiposity is associated with cell type-specific RNA
expression profiles of leptin, adiponectin, and their receptors in breast tumors and the adjacent breast TME; (2)
Define associations between RNA expression profiles of leptin, adiponectin, and their receptors in the breast
TME with tumor clinicopathology; and (3) Characterize RNA expression profiles associated with leptin,
adiponectin, and their receptors in the breast TME to predict breast cancer recurrence and mortality. This study
will yield novel insights on how adipose tissue distribution impacts gene expression profiles in the breast TME
and new information about potential differences by race and ethnicity and tumor subtype. Such data are critical
for efforts to integrate tumor markers and systemic factors into breast cancer risk and outcome prediction models,
and to informing the development of precision prevention interventions and precision therapeutics for diverse
breast cancer patients.

Public health relevance
PROJECT NARRATIVE Excess adiposity is independently associated with recurrence risk and death in hormone receptor-positive breast cancer, but, among non-Hispanic Black women and hormone-receptor negative breast cancer cases, associations are less clear. We will test the central hypothesis that adipose tissue depots (visceral vs. subcutaneous), measured using computed tomography scans, have differing associations with adipokine and adipokine receptor gene expression profiles and related gene signatures in the breast tumor microenvironment, which can be used to develop outcome predictive models. This high impact study will advance the field by yielding new data on how adipose tissue distribution impacts (1) gene expression profiles in the breast tumor microenvironment and (2) breast cancer outcomes, with an emphasis on the interplay among race and ethnicity and tumor subtype.